Role of Tissue-Specific Factors in the Control of Immunity

Maintenance of tolerance and restoration of host homeostasis following insults relies on a complex and coordinated set of innate and adaptive responses. Tissue tailored responses are controlled by specialized populations of cells that integrate local cues such as defined metabolites or cytokines in order to induce responses in a way that preserve the functional requirements of each tissue. Our work helped to identify specific tissue specific immunological networks and their role in the development of controlled or inflammatory immune responses. Notably our work identified mechanisms by which the host acquires tolerance to food and commensal antigens and how inflammation disrupts these regulatory pathways. Our current work explores additional mechanisms of regulation by tissue resident and inflammatory cells and identifies key factors controlling the function and survival of regulatory and effector cell populations at barrier sites.